EFFECT OF SALT LOADING ON VERAPAMIL BIOAVAILABILITY

The aim of this study is to determine, using stable-label methods, the extent of systemic availability of another CYP 34A substrate, verapamil, during sodium-defined diets in normal human volunteers.